Predictive methods for simulating redox reactions and charge transfer in proteins

Project Summary/Abstract
At Boston University (BU) the PI has developed a broad interdisciplinary computational and theo-
retical chemistry program focused on photo-induced and electron-mediated processes. The program
integrates method development and phenomenon-driven research closely tied to experiment through
collaboration with experimental groups at BU and elsewhere. Below the main developments pertain-
ing to the proposed program are summarized followed by an outline of the future research directions.
The PI has developed a first principle protocol that enables predictive simulations of redox po-
tentials of co-factors in proteins from the first principles. While electrostatic embedding QM/MM
is still a standard in the field, the PI has shown that polarizable embedding is often critical for
reliable estimates of redox potentials. The proposed scheme also correctly accounts for long-range
electrostatic interactions, rectifying an oversight of earlier approaches. It has been shown that this
model yields accurate estimates of redox potentials and electron transfer rates by using cryptochrome
protein as an example.
To enable fast high-throughput the PI has developed a web-based software, eMap, that enables
automated mapping of ET channels in proteins only based on their crystal structure. eMap parses a
PDB structure file, identifies all relevant redox-active moieties, constructs distance maps, and uses
graph theory to identify the most efficient electron transfer pathways. The software is now being
actively used by research groups outside BU for guiding the experimental studies as evidenced by
citations.
In the next five years, the PI plans to push the frontiers of the predictive simulations with the
final goal of building an umbrella platform that enables simulations of redox chemistry and electron
transfer from the first unbiased qualitative predictions to accurate quantification of observables. The
PI plans to take eMap analysis to a new level by enabling large-scale screening of protein families
for shared electron transfer pathways to explore the role of conserved electron transfer channels for
protein functions’ evolution. The PI also will enhance the predictive power of eMap through the
integration of the chemically-relevant energetic parameters without sacrificing the efficacy of the
method. The PI will be addressing the remaining challenges in the quantitative description of the
redox potentials of co-factors in proteins as well as the energetics of biological charge transport.
These advances together with the prior developments will allow the PI to bring the computational
program in the research group to the next level by significantly expanding the exploratory mechanistic
computational studies enabled by new software functions and level of accuracy.

Public health relevance
Project Narrative The proposed program will yield an overarching computational platform for simulating redox chemistry and electron transfer in proteins. The new mechanistic knowledge will advance our under- standing of fundamental biological processes, such as long-range electron transfer and redox reactions in enzymes, which in turn will lead to the design of alternative anti-microbial therapeutics.